Prolonged Nightly Fasting as a Behavioral Intervention for Obesity Reduction and the Prevention of Progression in Precursor Multiple Myeloma

PROJECT SUMMARY
Multiple Myeloma (MM) is an incurable and fatal plasma cell dyscrasia that always evolves from the precursor
conditions of monoclonal gammopathy of undetermined significance (MGUS) and smoldering MM (SMM).
Evidence-based strategies for preventing and intercepting the progression of MGUS/SMM to overt MM are
lacking, underscoring the importance of focused research in this area. Substantial evidence indicates that
obesity is a risk factor for MM and its precursor conditions. Therefore, interventions that target obesity and/or
obesity-related mechanisms of carcinogenesis may serve as possible MM prevention and interception
strategies in individuals with MGUS and SMM who are overweight or obese. The research will explore the
premise that habitual prolonged nightly fasting is a novel strategy to promote obesity reduction and intercept
disease progression in the large proportion of MGUS and SMM patients in the US who are overweight and
obese. We focus on prolonged nightly fasting over more traditional multifaceted weight-loss programs
because prolonged nightly fasting involves a simple behavior change that most individuals can understand and
adopt. We have previously developed a telephone counseling and text messaging-based prolonged nightly
fasting (PROFAST) intervention and tested it for one-month in a sample of obese, postmenopausal women at
risk for breast cancer and found it to be both achievable and acceptable in that sample of women. The
proposed study will build on this prior research by testing a refined version of the PROFAST intervention in a
sample of 40 overweight and obese individuals diagnosed with MGUS and SMM. Participants will be randomly
assigned, in equal numbers, to the PROFAST intervention or a healthy lifestyle education control for four
months. The intervention is designed to promote a 14 hour nightly fast and will be delivered in the form of
telephone-based health coaching and text-messaging. The overall objective of the research is to acquire
preliminary outcome data suggesting the efficacy of the PROFAST intervention in in 1) improving body
composition, and 2) altering clinical signs of disease progression to MM. As an exploratory objective, we will
explore the impact of the PROFAST intervention on bone marrow adipose tissue (BMAT), which is a
metabolically active adipose depot that resides near MM cells in the bone marrow. Upon completion, the
proposed study will provide the preliminary foundation of evidence for a larger, more definitive trial.

Public health relevance
PROJECT NARRATIVE Obesity is a well-established risk factor for numerous neoplasms, including multiple myeloma (MM), and is the only modifiable MM risk factors that has been identified. This study is positioned to aid in the discovery of feasible and sustainable interventions that can intercept disease progression in overweight and obese individuals with monoclonal gammopathy of undetermined significance (MGUS) and smoldering multiple myeloma (SMM), who have a high lifetime risk of developing MM but lack evidence-based strategies to prevent progression. Notably, findings generated from the study are expected to contribute to a paradigm change in the clinical care of patients with MGUS and SMM, e.g. from a watch and wait approach, to a paradigm of early intervention to prevent disease progression to MM.